Using Big Data to Help Inform SARS-CoV-2 Therapeutics Development

The overall goal of this project is to generate in-depth understanding of SARS-CoV-2 infection across multiple species and identification/comparison of therapeutics by incorporating organ on a chip technology into the existing preclinical animal work and analysis of human clinical samples.